The biochemical, topological and functional impact of cancer-associated Ctcfmutations and their contribution to cancer

PROJECT 1: SUMMARY
CTCF is an eleven-zinc finger protein that is known to play a key role in organizing chromatin into self-interacting
topologically associating domain (TAD) structures by promoting the formation of cohesin-mediated loops and
insulated boundaries. A number of labs (including the Skok lab) have shown that disruption of insulated TAD
boundaries by deletion of CTCF binding sites can alter gene regulation leading to defects in developmental
processes and cancer initiation as a result of illegitimate enhancer promoter contacts. Physical contacts between
cis regulatory elements (CREs) and the genes they control occurs via cohesin-mediated loop formation. Although
contacts commonly form between a single CRE-promoter pair, we and others have found that gene regulation
can also occur in ‘CRE hubs’, regions that encompass multiple genes and control elements that co-regulate each
other through chromatin looping. CTCF dependent and independent interactions can be conserved, or cell-type
specific, but while the role of transcription factors in promoting CTCF independent loops is known, the underlying
mechanisms of cell-type specific CTCF mediated loops have not yet been elucidated.
There are numerous CTCF motifs in the genome, but only a fraction of these are bound by CTCF in any cell
type. Since CTCF’s binding profiles are known to be cell-type specific, chromatin accessibility is presumed to be
important for CTCF binding. However, our preliminary data shows that CTCF can bind consensus motifs at both
inaccessible and accessible sites. Nonetheless, CTCF has a stronger signal and is more competent at blocking
cohesin and forming loops that orchestrate chromatin architecture when bound to accessible chromatin. But
accessibility per se, does not predict CTCF binding because the majority of accessible motif containing sites are
not bound by CTCF. Bioinformatic and RNA-seq analyses revealed that CTCF binding is linked to enrichment of
motifs of expressed TFs abutting (within 20bp) these sites. Moreover, motifs are also enriched within 20bp of
CTCF bound inaccessible sites but in contrast to bound accessible sites, the TFs are expressed at a lower level.
This result indicates that a change in transcriptional program might be able to flip an inaccessible CTCF bound
site to an accessible bound site in which newly bound TFs lead to a stronger CTCF signal capable of blocking
cohesin.
As part of this application, we aim to study the impact of transcriptional programming on CTCF binding and
function at the global level and in CRE hubs across cell state transitions. Use of CTCF mutants (whose graded
effects act as CTCF perturbations) will enable us to investigate direct and indirect CTCF-mediated effects on
hub rewiring (Figure 1) at an unprecedented level to examine the underlying CTCF-dependent mechanisms of
CRE hubs, using not only multi-way but also multi-omics and genome-wide single molecule approaches.

Public health relevance
PROJECT 1: NARRATIVE The CCCTC-binding factor (CTCF) is a highly conserved protein that plays a crucial role in organizing chromatin structure and gene expression. Project 1 will study WT and nine high-frequency cancer-associated CTCF mutants in the background of distinct transcriptional programs to determine how CTCF-mediated looping contributes to the control of cis regulatory element (CRE) hubs, regions that encompass multiple genes and enhancers that co-regulate each other through enhancer-promoter chromatin looping. This study will provide fundamental insights into the mechanisms of CTCF-mediated chromatin organization and gene regulation in the context of transcriptional programming, with significant implications for understanding the etiology and treatment of human diseases, including cancer and developmental disorders.